Cell Surface Receptor Recognition and Membrane Fusion in Mammalian Fertilization

Fertilization is an essential biological process that involves cell surface recognition, adhesion, and fusion of
haploid sperm and egg to form a new, genetically distinct diploid organism. Surprisingly little is known
about how plasma membranes interact and fuse, largely due to the limited availability of mammalian
gametes and the technical challenges of capturing transient extracellular interactions. While the gamete
membrane fusion machinery remains elusive, it is known that a human immunoglobulin superfamily
protein, Izumo1, localizes to the equatorial segment of spermatozoon, where it interacts with an oocyte
ligand, Juno, before gamete fusion takes place. To date, Izumo1-Juno is the only essential receptor-ligand
pair identified in the pathway. Recent genetic studies in mice have identified additional sperm surface
proteins essential for male fertility, but their interactions and regulation have not been defined. To close
these major gaps, I have designed a research program around the central hypothesis that gamete surface
proteins orchestrate their structural rearrangements and membrane remodeling, leading to gamete fusion.
I will test my hypothesis by (1) determining the assembly mechanisms of sperm fertilization protein
IZUMO1, (2) characterizing the roles of sperm fertilization proteins in membrane adhesion and fusion, and
(3) identifying additional receptor-ligand interactions essential for fertilization. My multidisciplinary
approach leverages high-resolution structural analyses to interrogate the functional organization of known
essential gamete surface proteins, and harnesses high-throughput forward genetic screens to explore the
interacting networks of additional emerging molecules. I have extensive training in genetics, cell biology,
membrane biochemistry, protein engineering and structural biology. At Yale, my research laboartory aims
to understand the mammalian sperm-egg fusion process at the levels of cell biology, mechanistic
biochemistry, and structural biology. Crucially, understanding these processes will elucidate mechanisms
of cell-cell adhesion and fusion and reveal essential factors for human fertility and reproductive health.

Public health relevance
Membrane fusion of sperm and eggs is pivotal in sexual reproduction, but its molecular mechanisms are largely unknown. The proposed research will characterize the assembly and architecture of the sperm fertilization membrane proteins, as well as identify and characterize new cell-surface interactions in sperm-egg recognition, adhesion and fusion. Understanding the functional organizations of sperm-egg interactions has direct impact on human fertility and reproductive health.